High Speed Large Area Detector for LCLS

Project Summary
This proposal aims to bring revolutionary next generation x-ray detector technology to the field of X-ray Free
Electron Laser (FEL) based structural biology.
X-ray FELs produce extremely short pulses of x-rays which can be exploited to obtain unique information about
the structure and the dynamics of biological systems. These short bursts of x-rays allow data to be collected
prior to the onset of radiation damage, resulting in higher resolution structural information compared to more
traditional measurements. Additionally, the ultrashort pulses are ideal to study fast dynamics. Combined with
data collection under ambient conditions, recently developed X-ray FEL methods of femtosecond crystallography
provide unique capabilities to study biological dynamics under physiologically relevant conditions with high
spatial and temporal resolution.
Over the last 10 years the technique of femtosecond crystallography has evolved from its first demonstration in
2011 to a very useful tool for structural biology. Even though the field of femtosecond crystallography using FEL
sources is still young, the detector technology has rapidly evolved since the start of operations of the Linac
Coherent Light Source (LCLS). The detector system currently used at the Macromolecular Femtosecond
Crystallography (MFX) instrument – the flagship instrument for bioscience research at LCLS – is significantly
outdated and in great need of modernization. A large worldwide effort to develop new detector technology has
produced paradigm-changing capabilities that are now available for scientific use. High dynamic range, fast (>2
kHz) detectors with single photon sensitivity and very low noise are now available. Such detectors are specifically
designed for ultrashort pulses from X-ray FELs and can maximize the information collected from the single shots
necessary for data collection prior to the onset of radiation damage.
This proposal is to purchase a recently available Jungfrau 15M detector which will surpass by more than a factor
of five the repetition rate and the dynamic range of the detector currently used for serial femtosecond
crystallography at the MFX instrument at LCLS, while reducing the noise level. This will greatly improve the
performance of LCLS femtosecond crystallography, allowing more access to the facility by providing higher
quality data faster. It will also enable fundamentally new capabilities by allowing ever more challenging biological
problems to be solved at LCLS. This detector will keep MFX instrument at LCLS at the forefront of X-ray FEL
biology by continuing to provide a world-leading tool for solving uniquely challenging biological problems that
conventional methods cannot solve. This will benefit important areas of biomedical research such as metallo-
enzymes, membrane proteins, GPCRs and large protein complexes, as well as generally provide more broadly
accessible capabilities to study the dynamics of biomolecules.

Public health relevance
Project Narrative Biological macromolecules are an essential part of every living organism on this planet and their shape - or three-dimensional structure - is directly responsible for their function. Knowing how biomolecules look can help to understand the way they work in health and disease. The X-ray laser at Stanford is used to take pictures of biomolecules with large area fast detectors with unprecedented level of detail. This unique tool enables to design effective and safe drugs.